DNA Damage, Mutation and Cancer GRC and GRS

Abstract:
The objective of the Gordon Research Conference (GRC) on DNA Damage, Mutation & Cancer and the
associated Gordon Research Seminar (GRS) is to bring researchers at all levels (faculty, researchers from
industry, postdocs, graduate students) together in person to discuss the latest topics in DNA repair, replication,
and genome instability that relate to cancer and other diseases. The meeting is held in the beautiful and relaxing
setting of Ventura, California. Consistent with past meetings, we anticipate that there will be ~200 participants.
Following the pandemic, however this GRC will take place at a period when interest in Science relating to human
health is at an “all time high”. This meeting provides critical insight to the consequences of DNA damage for
genome integrity and cancer avoidance, as well as advances in treating cancer with novel inhibitors that are
bolstered by underlying defects in DNA repair and replication stress responses. Furthermore, a range of
technologies relating to DNA damage repair are being harnessed for cures in a diverse set of human diseases.
For example, therapeutic genome editing requires understanding and manipulating DNA repair. As always, we
will feature an exciting scientific program with the overall goal of promoting positive interactions and the sharing
of unpublished research. The GRC will feature ~35 invited speakers representing diverse scientists with respect
to age, gender and geographic origin representing academia, industry and physician scientists. Moreover, there
will be ~8 oral presentations selected from abstract submissions and 4 interactive poster sessions. The invited
speakers represent the field broadly and are leaders in their respective fields. The Power Hour afternoon session
will discuss challenges to women in science, challenges to minorities in science, and establish new networking
interactions. At some of the dinners there will be theme tables, one night based on scientific topics and another
night based on mentoring and career options, to encourage participation of students and postdocs and to help
interactions between these groups and senior scientists. The GRS will have 8 postdoc/student presentations
selected from abstracts, an introductory keynote lecture, a career panel discussion and two poster sessions. The
GRC/GRS meeting schedule allows for plenty of time for informal discussions during sessions, meals and free
time.

Public health relevance
Narrative This meeting will focus on DNA damage and replication dysfunction that are the cause of genomic instability, predisposition to cancer, neurodegeneration, and aging. Furthermore, DNA damage and replication stress are the basis for cancer therapies that also induce the immune response. Collectively, the goal will be to understand the DNA damage and replication stress responses from external (environmental, medicinal) and internal (genetic or epigenetic) sources, to cellular signaling, and cell death responses to impact human disease.